The role of the cerebellum in speech

PROJECT SUMMARY
Cerebellar ataxia (CA), caused by degeneration of or insult to the cerebellum almost always results in dysarthria,
a speech motor impairment that results in reduced intelligibility and naturalness, significantly impacting quality
of life. A mechanistic understanding of the cerebellar contribution to speech as well as how damage to this
subcortical structure impacts cerebral speech networks is poorly understood. Consequently, at present there are
no evidence-based treatments to improve speech production in CA. Our central objective is to close this
critical gap by determining how cerebellar dysfunction impairs the neural control of speech, a crucial
foundational step to enable development of mechanism-based treatments for CA speech impairments.
Our central hypothesis is that the cerebellum plays a critical role in the feedforward control of speech, the
ability to produce speech without monitoring its sensory outcomes. Specifically, the cerebellum is involved in the:
1) generation of sensory predictions used for feedforward control and 2) updating of these predictions following
feedback errors (i.e., mismatch between predicted and actual feedback) to maintain an accurate internal model
for feedforward control. While feedforward control may provide a general characterization of how the cerebellum
contributes to speech production, we hypothesize that different subregions of the cerebellum are associated with
specific, and dissociable aspects of speech production such as articulation, pitch, and timing. We further hypoth-
esize that cerebellar damage has little direct effect on feedback control, the ability to use sensory signals to
guide and correct ongoing actions patients may develop idiosyncratic changes in feedback control as a compen-
satory mechanism for impaired feedforward control.
In two aims, we test these hypotheses by analyzing the relationship between cerebellar degeneration, speech
symptoms, and specific motor control impairments (Aim 1) and examining the role of the cerebellum in the
broader speech production network (Aim 2). Across these aims, we will address a striking clinical observation,
namely the wide heterogeneity observed in CA patients in terms of their dysarthria, a phenomenon that is poorly
understood. We evaluate three promising sources that may underlie this heterogeneity: 1) differences in the
specific locations of degeneration/pathology, 2) differences in CA etiology, and 3) compensatory changes in
control that may develop secondary to cerebellar damage itself. We will use speech psychophysics in conjunction
with magnetoencephalography (MEG) imaging to examine the consequences of cerebellar damage on electro-
physiological responses in the cerebral cortex associated with speech motor control and learning in three model
cohorts: 1) patients with CA, 2) patients with acute cerebellar stroke (ACS), and 3) healthy speakers in whom
cerebellar function is transiently perturbed by continuous theta-burst transcranial magnetic stimulation (cTBS).

Public health relevance
PROJECT NARRATIVE – RELEVANCE Our central objective is to determine the role of the cerebellum in the control of speech and how damage to it impacts the broader speech network. Using speech psychophysics, magnetoencephalography (MEG) imaging and transcranial magnetic stimulation, we conduct a set of experiments examining: 1) the relationship between cerebellar degeneration and speech motor control impairments; and 2) the role of the cerebellum in the broader speech production network. This work will form the foundation for the development of novel treatments for speech impairments caused by cerebellar damage.